A spatially resolved single-cell transcriptomic technique for microbial pathogenesis

Image-based approaches to single-cell transcriptomics are an emerging suite of technologies that allow large
fractions of the transcriptome to be directly imaged and quantified within single cells. One such method—
MERFISH—has emerged as a leader given its unique combination of high spatial resolution, high detection
efficiency, single-molecule sensitivity, transcriptome-wide multiplexing, large throughput, and proven ability to
discover, identify, functionally annotate, and map a diverse range of cell types within intact mammalian tissues.
Such methods offer tremendous promise for the study of bacterial systems. They could discover and profile
rare but clinically relevant populations of antibiotic resistant cells, define and characterize new mechanisms of
virulence factor regulation from correlations in gene expression, and link the internal organization of the bacterial
transcriptome to our growing understanding of its regulatory capacity. Moreover, such methods promise the
ability to map bacterial gene expression in native contexts, revealing spatial gradients in bacterial behavior in
microbial communities, cellular specialization in biofilms, host-pathogen interactions at infection sites, and the
behavior of unculturable bacteria in their natural communities, to name only a few exciting applications.
Unfortunately, there are no spatially resolved single-cell transcriptomic methods for bacteria. Thus, to
address this need, we will create bacterial-MERFISH. We will use expansion microscopy—a super-resolution
approach that physically expands samples to enhance optical resolution—to overcome RNA densities and will
explore, optimize, and validate a suite of expansion chemistries and gel anchoring methods that promise
bacterial volumetric expansions of 100- to 10,000-fold. We will develop and benchmark bacterial-MERFISH in
two model bacteria, E. coli and B. subtilis, at two scales, ~200 genes and transcriptome-wide (~2000 genes).
We will then demonstrate the discovery potential of bacterial-MERFISH with two focused studies of the
mouse intestinal pathogen, C. rodentium—a model of human enteropathogenic E. coli infections. First, we will
leverage single-molecule sensitivity and single-cell resolution to explore virulence factor (VF) regulation in C.
rodentium cultures with the goal of characterizing multiple pathogenesis aspects, including a recently described
sub-population of pathogenic ‘active’ EPEC in VF repression conditions. Second, we will explore gene
expression in C. rodentium and the surrounding microbiome during intestinal infection in the mouse. We will
infect mice harboring a defined microbiota—the Altered Schaedler Flora (ASF)—and profile whole-transcriptome
gene expression in C. rodentium and key stress and metabolic pathway expression in all 8 members of the ASF
in slices of the mouse cecum and colon at defined time points during infection. The single-cell, spatial-gene-
expression atlases we will create promise new insights into local remodeling of pathogen, microbiome, and,
eventually, host. With its combination of spatial resolution, sensitivity, and transcriptome-wide multiplexing, we
anticipate that bacterial-MERFISH will find immediate use in the study of a wide range of bacterial systems.

Public health relevance
Spatially resolved single-cell transcriptomics methods have a proven ability to discover, define, and map mammalian cells in a range of tissues. Here we will extend these abilities to gene profiling in bacteria, providing a method that can measure single-bacterial-cell gene expression, define heterogeneous response, map the internal organization of the bacterial transcriptome, and profile bacterial gene expression in the context of mixed microbial communities and pathogenic infections. We will validate this approach in model organisms and demonstrate its use to reveal new aspects of a model of bacterial-induced diarrheal disease.